Biocontainment Research Support Service(s) Core-Optional

Project Summary/Abstract:
Core 3 outlines a strategic plan to establish integrated core services within the UAB SEBLAB
enabling safe and efficient use of the cutting edge scientific equipment recently funded by NIAID
award 1G20AI167409-S1. This proposal establishes six functional integrated research cores
within containment including: 1. Cell Culture core to maintain and generate novel cell lines, 2.
Microbiology core to culture organisms, modify, and maintain stocks, 3. In vitro core to operate
high resolution imaging and high-throughput screening platforms, 4. In vivo core to operate high
complexity non-invasive imaging platforms, 5. Single Cell core to perform flow cytometry, cell
sorting, and single cell partitioning, and 6. Pandemic Preparedness core to develop medical
countermeasures and drive IRB-approved high containment research requiring clinical samples.
Each core will be operated by a scientific research team, including the PI on this application,
one senior scientist, and two junior scientists. This scientific team will work closely with UAB
Core lab directors, Biosafety, and SEBLAB end users to optimize high containment research
productivity.